A novel strategy to overcome the P-gp/BCRP drug efflux system at the blood-brain barrier to improve brain uptake of CNS therapeutics

Failure of anticancer drug treatment is largely due to overexpression of the P-gp/BCRP drug efflux system at
the blood-brain barrier. New evidence suggests that glioblastoma multiforme (GBM) induces P-gp/BCRP over-
expression in capillaries of the brain hemisphere that is contralateral to the tumor. Thus, after surgical removal
of the primary tumor, remnant tumor cells that are scattered throughout the brain remain shielded from anti-
cancer drugs. This poses a significant clinical problem and represents an unmet critical need to develop strat-
egies to overcome P-gp/BCRP. The absence of such strategies will likely prevent improvements in GBM ther-
apy. The long-term goal of the investigator is to identify molecular mechanisms that control blood-brain barrier
function and can be targeted to improve brain uptake of anticancer drugs. The overall objective of this applica-
tion is to develop an effective therapeutic strategy to overcome P-gp/BCRP-mediated anticancer drug efflux
and prolong survival in mice with GBM. Based on preliminary data the central hypothesis is that GBM induces
P-gp/BCRP overexpression and that inhibiting PI3K/Akt will decrease P-gp/BCRP overexpression, which will
increase brain uptake of anticancer drugs, thereby reducing tumor size and prolonging GBM mouse survival.
The rationale for this research is that its successful completion is expected to provide a solid, evidence-based
scientific framework for translating our strategy into the clinic. Based on strong preliminary data, this hypothesis
will be tested by pursuing three specific aims: 1) Determine the mechanism(s) by which GBM induces
P-gp/BCRP overexpression; 2) Identify pathways that regulate P-gp/BCRP at the human blood-brain barrier;
and 3) Develop a therapeutic strategy to increase anticancer drug brain uptake in GBM mice. Under the first
aim, mechanistic steps involved in GBM-induced overexpression of P-gp/BCRP will be assessed in brain capil-
laries of the hemisphere contralateral to the primary tumor. The impact of blocking these steps on brain uptake
of anticancer drugs in GBM-bearing mice will be determined. Under the second aim, P-gp/BCRP regulation by
the PTEN/PI3K/Akt/mTOR pathway will be determined in brain capillaries from normal individuals and from
GBM patients. Under the third aim, the therapeutic benefit of combining PI3K/Akt inhibitors with anticancer
drugs to reduce P-gp/BCRP levels with the goal of improving brain uptake of anticancer drugs and prolonging
survival will be assessed in three different GBM models. The proposed research is innovative, in the appli-
cant's opinion, because it represents a new and substantive departure from the status quo by shifting the focus
to GBM-induced overexpression of blood-brain barrier P-gp/BCRP in the contralateral hemisphere and by uti-
lizing a molecular switch-based approach to overcome P-gp/BCRP-mediated drug efflux to target remnant tu-
mor cells distant from the primary tumor. The proposed research is significant because it is expected that the
new knowledge may have broad translational importance in the treatment of patients with GBM and potentially
other brain tumors as well.

Public health relevance
The proposed research is relevant to public health because it is expected to provide a novel treatment strategy to overcome blood-brain barrier drug efflux for improved delivery of therapeutics into the brain, specifically anticancer drugs. Thus, the proposed research is relevant to the mission of the NIH/NINDS that pertains to developing fundamental knowledge that will help reduce the burden of neurological disease.